Vanderbilt-Emory-Cornell-Duke Global Health Fellowship Consortium-Expanding Diversity for Global Equity (EDGE)

PROJECT SUMMARY ? PARENT APPLICATION The Vanderbilt-Emory-Cornell-Duke Consortium for Global Health Fellows (VECDor) comprises institutions with decades-long global partnerships with premier LMIC research institutions in Africa (Ethiopia, Ghana, Kenya, Mozambique, Nigeria, Rwanda, Tanzania, and Zambia), Asia (India and Vietnam), Central America (Guatemala, Honduras, and Nicaragua), and the Caribbean (Haiti). VECDor's collective research portfolio encompasses diverse and complementary foci in both communicable and non-communicable diseases (NCDs), with particular strengths in NCDs and HIV/TB. VECDor institutions and faculty bring substantial investigative accomplishment and mentoring excellence, evidenced by successfully supporting 87 highly productive VECDor Fellows and Scholars in 2012-2017, many of whom now have R or K or similar career development grants of their own. Our efficient support center has been honed over 10 years of Fogarty Scholars and Fellows research training administration, and maximizes the flow of funds for research training. In 2017-2022, we will continue to leverage multiple sources of financial and in-kind co-funding and link with multiple institutional and NIH-funded training programs and with minority institution partner Meharry Medical College to select and deploy 80 to 100 US and LMIC trainees with outstanding promise for global health research careers. We are innovating by enhancing diversity in the consortium's leadership, adding and expanding strategic training sites in Central America, Vietnam, and West Africa, and increasing NCD research opportunities. We will enhance our mentorship plan by adding tailored short-term training workshops at VECD institutions before field deployment; enlisting accomplished VECDor alumni in trainee advising; and providing post-fellowship training in grant writing and career coaching, to optimize the quality of scholarly output and trainee success in obtaining research and career development grants and positions. Research themes will address all topic and geographical areas of interest to trainees and sponsoring NIH Institutes and Centers. We will continue to document impacts with our established monitoring and evaluation tools that successfully track the career trajectories and outputs of all trainees, and will further refine our web-based tools to share knowledge, foster local and global networking, and strengthen and sustain clinical research skills among VECDor trainees and alumni. VECDor is built on mutually respectful and constructive relationships among its partners, our collective record of research innovation and mentorship, and successful capacity building with our LMIC partner institutions. Combining our extensive experience in research training program management, robust research funding in diseases of global significance, renowned international research training partners and sites, and sustained institutional leveraging, VECDor will continue to nurture global health research leaders of the 21st century.

Public health relevance
PROJECT NARRATIVE Many of our U.S.-based Vanderbilt-Emory-Cornell-Duke (VECD) Fogarty Global Health Fellowship applications reflect the global health shift in recent years to an increased emphasis on qualitative and mixed methods approaches to answer outstanding questions and provide new insights into issues of prevention and treatment. However, our low- and middle-income country (LMIC) participants are much less likely to have knowledge of or training in these areas, nor do they have sufficient institutional mentorship in qualitative or mixed methods research, putting them at a disadvantage for attracting funding from certain NIH Institutes and Centers for their fellowship year and, in subsequent years, for their research projects. This supplemental project seeks to narrow this gap and build capacity (in line with our parent project goals) by providing intensive in-country workshops at two of our partner VECD sites and developing selected in-country individuals to serve as institutional leaders in qualitative and mixed methods research design and implementation.